Determining mechanisms of innate immune modulation by ADP-ribosylation

PROJECT SUMMARY
The mammalian antiviral response is largely controlled by post-translational modifications (PTMs), the
addition of small proteins, chemicals, lipids, or sugars to proteins to quickly alter their function. Phosphorylation
and ubiquitination are well known PTMs that play key roles in the antiviral response. However, research has
demonstrated that ADP-ribosylation, the addition of single (mono-ADP-ribose or MAR) or multiple (poly-ADP-
ribose or PAR) ADP-ribose units onto proteins, is also critical, as it both negatively and positively regulates key
proteins in these pathways. However, the mechanisms by which ADP-ribosylation controls the antiviral response
are not fully understood. ADP-ribose is added to proteins by ADP-ribosyltransferases, better known as PARPs.
On the other side of the reaction, macrodomains are proteins that both bind and erase MAR on protein
substrates. All coronaviruses (CoVs) encode for a macrodomain (Mac1), indicating that CoVs are highly sensitive
to MAR. Reverse genetic approaches that remove Mac1 activity from CoVs make for excellent model systems
to study how MAR functions in the antiviral response, as Mac1 is the only CoV protein that counters MAR, and
prior studies had determined by Mac1 was critical for the ability of CoVs to replicate and cause disease.
The investigator’s long-term goal is to determine how ADP-ribosylation inhibits virus replication and
enhances the innate immune response. Using Mac1 mutant CoVs and other model systems, the PI’s group has
demonstrated that MAR independently represses both CoV transcription and protein production in the absence
of Mac1, and that MAR promotes interferon (IFN) production following RNA virus infection. PARP12 and PARP14
were identified as PARPs that restrict Mac1 mutant virus replication, and PARP14 enhances IFN responses.
Furthermore, a novel PARP14/PARP1 interaction has been identified and this interaction likely contributes to the
ADP-ribose-dependent induction of IFN. However, many of the mechanistic details driving these phenotypes
remain unknown. The major questions being addressed are: I) How does MAR restrict CoV transcription (1)
and protein accumulation (2) and what host factors mediate this restriction? II) What are the molecular
determinants of the PARP1/PARP14 interaction (3), and how do PARP1 and PARP14 together drive the
IFN response (4)? These proposed studies will provide more mechanistic data regarding the functions of ADP-
ribose during infection. The rationale for this research is that it and will uncover novel cellular proteins or
processes that repress virus replication and promote IFN production. The work is innovative because it explores
unique cellular targets of ADP-ribosylation that have not previously been implicated in a CoV infection. Finally,
these projects are significant and relevant to the NIGMS mission because they will provide a more thorough
understanding of how MAR impacts the anti-viral response that could lay the foundation for advances in the
treatment of virus infections or other human diseases impacted by MAR.

Public health relevance
PROJECT NARRATIVE Viruses continue to impose a major public health burden on society, and a better understanding of the human anti-viral response could lead to novel methods to control virus infections. The mammalian anti-viral response is largely regulated by post-translational modifications (PTMs), including ADP-ribosylation; though it’s unclear precisely how ADP-ribosylation limits virus replication. The primary objective of this proposal is to identify mechanisms by which ADP-ribosylation represses virus replication and enhances the host immune response, with the goal of developing novel ADP-ribose based anti-viral therapies.